Multi-Stakeholder Consensus Approach to Problem Consolidation and Strategic Use of Electronic Health Record (EHR) Data Standards for Clinical Research and Regulatory Reporting

Project Summary/Abstract
The use of electronic health record (EHR) systems as a source of “real-world data” (RWD) has great potential
to transform and improve research. Despite the potential value and public health need for RWD, the ability to
extract and use data from EHR systems for research is limited due to the absence of clearly defined and
uniformly implemented standards that represent the semantic meaning of clinical data, including the context
and specificity of coding. A particular challenge is that clinical coding systems used for EHR data often have
very granular codes to support documentation of detailed diagnoses and highly specific tests and packaged
medications. These granular codes must be grouped into broad concepts for research analyses and
submissions, but consistent and reproducible data aggregation methods that preserve important semantic
meaning and context of clinical RWD for research purposes are lacking. We propose to use a well-informed
environmental scan, targeted literature review, and a multi-stakeholder group of standards experts to identify
unresolved methodological issues and critical challenges – and delineate alternative approaches for
standardization or harmonization - that can support strategic action for leveraging RWD in the short term and
enable a more robust clinical research infrastructure to support future research needs. The multi-stakeholder
group will include data and standards experts from both clinical informatics and research data standards
communities.

Public health relevance
Project Narrative The use of EHR data for clinical research is promising but limited due to lack of data standardization and concerns with data quality. The proposed research will leverage standards experts from clinical and research communities summarize the types and level of standardization of coded data collected in EHR systems, connect these data types to research-relevant standards, and define alternative approaches - and the strengths and weaknesses of each - to support the use of EHR data in regulated research.